Recruitment Core

PROJECT SUMMARY
The primary aim of the Recruitment Core will be to recruit and support 2 mid-level or senior faculty members
with established health equity research programs to fill gaps in institutional expertise, and to support the
missions of the Southwest Health Equity Research Collaborative (SHERC) and Northern Arizona University
(NAU). As such, the Recruitment Core is responsible for designing and conducting effective and viable
recruitment strategies to attract diverse pools of qualified applicants, including members of historically and/or
currently underrepresented (UR) communities, to consider positions at NAU. To do this, the Recruitment Core
will work closely with NAU’s Center for University Access and Inclusion (CUAI) and the Equity and Access
Office (EAO) to engage best practices, attract a diverse pool of applicants, including individuals from
underrepresented or disadvantaged backgrounds, and align purposeful support of UR faculty, staff, and
administrators with NAU’s Strategic Roadmap and Diversity, Equity and Inclusion guiding principles; NAU’s
Diversity Strategic Plan (DSP); and SHERC’s emergent diversity, equity, inclusion, and justice (DEIJ)
framework. Dr. Gabriel Montaño, the NAU Diversity Fellow, and past president of the Society for Advancement
of Chicanos/Hispanics and Native Americans in Science (SACNAS); Traci Harvey, Director of NAU’s Office of
Inclusion; and Hilary North-Ellasante, MA, DEIJ consultant, will provide guidance in achieving these goals.
Cultivating an inclusive environment is an ongoing practice; Mx. North-Ellasante will facilitate change work as
we build capacity to expand our commitment to diversity, and to communicate opportunities that exist at NAU
for faculty and scholars to contribute to our overall goal of advancing health equity in the southwestern United
States (US). A formative evaluation will focus junior and senior UR faculty experiences to understand their
needs and concerns, and to inform how we might best support and retain them as valuable contributing
members of our campus community. We also aim to: (1) support the new hires in establishing collaborative
and independent health equity research programs at NAU; and (2) incorporate the new hires into SHERC as
collaborators, mentors, and leaders.